Resource Support Core

PROJECT SUMMARY
The Resource Support Core (RSC) will provide infrastructure and tools to enable a cohesive approach to the
collection, analysis, storage and sharing of data across the SCORE projects. The RSC will also provide expert
support in areas such as biostatistics, transcutaneous vagus nerve stimulation, and advance autonomic and
neuroimaging analyses. Establishing a unified approach enhances the quality of all studies, allowing each
project to inform the others in potentially significant ways, and enabling valuable exploratory analyses through
the pooling of data collected by multiple projects. The noninvasive nature of MRI allows for multiple
experiments on an individual subject, either during the course of one examination period or on multiple
occasions, as proposed in the current proposal to accomplish the aims of projects 1 and 2. The imaging data
must be registered accurately, in both space and time, and interpreted to isolate physiological phenomena of
interest from extraneous noise sources. Three-dimensional, high-resolution, anatomical MRI images will
provide the basis for interrelating neuroimaging information. A broad range of functional imaging analytic tools
will then be applied to interrogate both resting brain state and task- and/or stimulus-induced regional activation.
The image analysis tools we propose have been extensively tested and validated by investigators at the
Athinoula A. Martinos Center for Biomedical Imaging, over many years. The RSC will provide access to this
broad neuroimaging expertise of the Martinos Center and will deliver a reproducible and efficient means to
obtain, analyze, test and correlate structural and functional neuroimaging with physiological data. The RSC will
also provide support on biomedical signal processing by developing and executing plans for advanced
mathematical modeling and processing of physiological measurements taken in both the animal and human
experiments. This will facilitate translational analyses of the mechanisms of autonomic dysregulation explored
in projects 1 and 3. Experts on the implementation of non-invasive vagus nerve stimulation techniques in
human and animal models have been included in the RSC and will assist in the experimental set up and
interpretation of vagal neuromodulation effects on behavioral, imaging and physiological outcomes in projects
2 and 3. Beyond acquisition and analytic support, the RSC is designed to support critical cross-project data
analyses. Cross-project synergy is essential to the overall SCORE research plan and built into the design of
the projects. This will allow for interesting and potentially valuable pooled analyses of the data and will permit
us to address larger-scale questions about sex differences in the neuroscience of the neural
pathophysiological mechanisms responsible for autonomic dysregulation in major depression and sex
differences in the effects of a novel transcutaneous vagal stimulation technique on the attenuation of these
alterations.

Public health relevance
Project Narrative The Resource Support Core (RSC) Core will provide technical support to synthesize and integrate neuroimaging, neuromodulation and physiological methods and analyses across the SCORE Projects. By providing a common image, physiological and experimental data acquisition and analysis framework, the RSC Core will facilitate the ability to perform intra- and inter-project analyses as well as larger-scale analyses. This will integrate not only the SCORE work, but other related NIH-funded studies at the institutions, allowing us to address on a still broader scale questions about sex difference in the neurobiology of MDD and the discovery work for the implementation of a novel, non-invasive therapeutic intervention. Thus, the RSC will increase the value of such data to the broader community when shared according to our Resource Sharing Plan.